15th Fellows Forum on Osteoporosis and Metabolic Bone Diseases

This application seeks support for the 15th Fellows Forum on Osteoporosis and Metabolic Bone Diseases. The conference will be held September 29-30, 2021, immediately prior to the Annual Meeting of the American Society of Bone and Mineral Research in the Toronto Convention Center, Toronto, Canada. The program will also be held virtually or exclusively using a virtual platform, depending upon the status of the Covid-19 epidemic. We expect to have approximately 90 postdoctoral trainees who are united by their research interests but who are training in a number of different basic and clinical specialties. The faculty will consist of 11 of the most highly valued thought leaders in the world. The ability of young investigators with promise to interact with this faculty in a setting of both didactic and interactive workshops has been and will continue to be a seminal experience, leading to a further commitment on the part of these fellows to train in osteoporosis and other metabolic bone diseases.

Public health relevance
The application seeks support for the 15h Fellows Forum on Osteoporosis and Metabolic Bone Diseases that will be held at the Toronto, Convention Center, Toronto, Canada, September 29-30, 2021